Regulation of MPNST pathogenesis by Chromosome 8 gene, UBR5

Project Summary
Neurofibromatosis type 1 (NF1) is a common neurogenetic cancer predisposition syndrome, affecting 1 in
3,000 individuals worldwide. While most of the tumors are benign neoplasms (neurofibromas, low-grade
gliomas), 10-13% of patients will develop an aggressive sarcoma, termed a malignant peripheral nerve sheath
tumor (MPNST). Composed of high-grade neoplastic Schwann cells, MPNST most often arise from a benign
precursor lesion, such as plexiform neurofibroma (PN). Unfortunately, even with aggressive multi-modality
therapy, these cancers recur in >50% of individuals, and most patients die within five years of diagnosis. For
this reason, there is an unmet need for better therapeutic modalities. To identify novel targets, we generated a
series of patient-derived xenografts (PDX) lines that more accurately reflect the molecular heterogeneity of
human MPNSTs. Using these PDX lines, we showed that MPNST exhibit a high degree of aneuploidy and
harbor gains involving the long arm of chromosome 8 (Chr8q). Detailed analysis of Chr8q genes revealed that
UBR5 is the most highly upregulated gene in MPNST and that UBR5 genetic knockdown (KD) decreased
MPNST proliferation, survival, and migration. Based on these exciting data, we hypothesize that UBR5 is a
key driver of MPNST pathogenesis and in part responsible for Chr8 gain-mediated MPNST malignant
progression. In this proposal, we will: (1) Define when in MPNST progression Chr8q gain occurs and if UBR5
expression through this molecular event correlates with worse overall survival. (2) Utilize a recently developed
human induced pluripotent stem cell plexiform model and a murine Nf1 mutant plexiform neurofibroma-prone
strain that develops MPNST following lentiviral manipulation of other genomic drivers to determine the
sufficiency of UBR5 to promote MPNST formation. (3) Determine the mechanism of action of UBR5 in MPNST
including how UBR5 regulates cell survival and whether its role is dependent on its E3 ubiquitin ligase activity.
The experiments outlined in this proposal will provide a deeper understanding of the molecular pathogenesis of
MPNST, which is required to uncover new opportunities for the development of novel therapeutic strategies
that may improve clinical outcomes.

Public health relevance
Project Narrative: Aneuploidy has been associated with a worse clinical outcome in many solid tumors, and specific chromosomal aberrations can be prognostic. Yet, little attention has been given to the role of aneuploidy in MPSNT. Our prior work has shown that Chr8 gain is a near universal event in MPNST and that the Chr8 gene, UBR5 is highly expressed in MPNST compared to the benign precursor, and promotes cell survival in. The goal of this proposal is to define when in malignant transformation Chr8 gain and UBR5 expression occurs, to determine if there is a correlation with overall survival, and to dissect the mechanism by which UBR5 functions in MPNST. These studies have the potential to impact early diagnosis, prognostication, and development of therapies for MPNST through a better understanding of the pathogenesis of this deadly cancer.